Pre-exposure Immunologic Health and Linkages to SARS-COV2 Serologic Responses, Endothelial Cell Resilience, and Cardiovascular Complications: Defining the mechanistic basis of high risk endotypes.

Pre-exposure Immunologic Health and Linkages to SARS-COV2 Serologic Responses, Endothelial Cell
Resilience, and Cardiovascular Complications: Defining the mechanistic basis of high risk endotypes.
Tim Chan
David A. Zidar
Abstract
The objective of this proposal is to understand the immunologic foundations of heart disease which can occur
as a result of COVID19. Cardiac impairment, when it develops is often fatal, and our hypothesis is that the
maintenance of endothelial function is critical to surviving the protracted nature of COVID19 pneumonia,
especially in those with reduced or delayed antibody responses.
Our first aim will be to analyze those differences in immune function which pre-date infection but appear
to impact the risk of fatal COVID. This will be done by enrolling those at high risk for developing COVID19
(frontline healthcare workers), and performing serially assessments of their immunologic function if they develop
COVID. We will specifically investigate the mechanisms that link pre-infection inflammatory pathways to
protective serologic responses and symptom severity and recovery.
Our second aim will be to perform in vitro experiments to assess the requirements for endothelial cell
dysfunction and infectivity. We will compare various inflammatory and cardiovascular stimuli which seem to play
a role in promoting COVID19-related cardiovascular complications.
Our third aim is to characterize immune cells, endothelial cells, and cardiomyocytes in heart tissue from
those with COVID19-induced left ventricular dysfunction. Using single cell sequencing techniques, we will
determine cellular and molecular signatures that characterize the microenvironment of the COVID19-affected
heart, compared to appropriate controls.
Our conceptual model is that pre-existing immune dysfunction 1) reduces the efficiency of neutralizing
antibody responses, and 2) in conjunction with cardiovascular disease risk factors, induces endothelial
downregulation/depletion of nodal regulators which protect against inflammatory insults. This renders
endothelial cells unable to withstand COVID-specific stimuli. Once completed, this study will provide the
necessary information to improve the identification of those at risk for COVID-related heart disease and develop
rationale approaches to improve the improve survival in the setting of COVID.

Public health relevance
SeroNet UO1- Remaining Activities 2025 Zidar David, Timothy Chan | 1 U01 CA 260513 Pre-exposure Immunologic Health and Linkages to SARS-COV2 Serologic Responses, Endothelial Cell Resilience, and Cardiovascular Complications: Defining the mechanistic basis of high risk endotypes. Project Narrative COVID-19, the disease resulting from SARS-CoV2 infection, has caused immeasurable death and economic hardship across the globe within months. Certain individuals, including those with impaired immune function and/or those with heart disease appear to be a higher risk from COVID19. Whether survivors develop protection from a second exposure add to the urgency to understand the details of how COVID causes death. Here, we will characterize baseline differences in immunologic activation and risk factors for heart disease and how these relate to immune system function after infection. We will also compare those who do and don’t develop heart failure in response to COVID19, identifying ways the virus may directly or indirectly attack distant organs such as the heart. By identifying the mechanisms which explain why some develop life-threatening disease whereas others are minimally affected, we hope to develop strategies to identify and prevent severe illness from developing in those with COVID.